Rage Against the Pain: An Alternative Yoga Program to Address Chronic Low Back Pain Among Veterans

Background: Low back pain is a leading cause of disability among US adults, and can drive opioid use and associated adverse outcomes. VA considers low back pain a significant problem and is highly motivated to take action to improve Veteran engagement in pain care (including complementary and integrative treatments). Yoga is recommended as a front-line treatment for low back pain, however, yoga adoption among Veterans is low. One potential barrier to adoption among Veterans may be their perceptions of yoga, which for some, encompass long-held but often inaccurate beliefs of what engaging in yoga entails and how their participation will be viewed by others. To facilitate uptake and sustained use of yoga, we propose to offer Veterans a different yoga experience that imparts the same pain management benefits but may better align with their preferences and resonate more with their interests. We call this yoga program, Rage Against the Pain (RAP) `High Intensity Stretching'. Significance/Impact: If this study finds that RAP is feasible and acceptable to Veterans who experience chronic low back pain, it will provide an innovative approach to address a top priority of the VA – using CIH programs for pain management and opioid use reduction. Our long-term goal is to develop a scalable and sustainable alternative yoga program to help Veterans with chronic pain who may not find other available pain management options to be appealing or effective. Innovation: Our proposed RAP program promotes yoga as less of a meditative, introspective activity done to quiet calming music and more of an expressive, active practice set to music commonly enjoyed among many Veterans (e.g., rock, metal). The development of RAP (and the program name) reflects direct Veteran feedback, and was inspired by “rage yoga.” We will draw upon and tailor the aspects of rage yoga that make the most sense for Veteran health needs, adopting the beneficial aspects of the concept (e.g., traditional yoga poses, alternative music, outward self-expression). Specific Aims: Our overall goal is to develop and evaluate the RAP program, intended to improve Veteran participation in yoga and by extension, outcomes among Veterans with chronic low back pain. Specific Aims are to: (1) Develop the RAP program, which will encompass finalizing the program curriculum, including music play-lists, cues for self-expression, and sets of yoga movements known to alleviate low back pain; (2) Examine the feasibility and acceptability of offering RAP for Veterans with chronic low back pain, and; (3) Gather preliminary data to provide the foundation for a future trial to examine the potential effectiveness of RAP on Veterans' outcomes and medication use. Methodology: Veterans who experience chronic low back pain will be invited to participate; eligible participants will be randomized into RAP or a Hatha yoga program. Classes will be 75 minutes long, held once a week for 12 weeks, and taught by VA recreation therapists who are certified yoga instructors. A comprehensive safety plan will be instituted. Program initiation and attrition will be tracked and compared between groups. Baseline and follow-up data on outcomes (pain intensity, interference and behavior; function; quality of life; sleep; depression; medication use) will be collected via survey. Veterans' experiences with and perceptions of the programs will be assessed through qualitative semi-structured interviews. Expected Results: We anticipate RAP will be well-received by Veterans, and expect that participation in RAP will be greater (and attrition lower) than a traditional yoga program. Implementation/Next Steps: Test the effectiveness of RAP and issues around its broader implementation in VA.

Public health relevance
If this pilot study finds that our Rage Against the Pain (RAP) program is feasible and acceptable to Veterans who experience chronic low back pain, it will provide an innovative approach to address a top priority of the VA – using complementary and integrative health (CIH) programs for pain management and opioid use reduction. The next step is to test the effectiveness of the program and issues around its broader implementation in VA using a Hybrid Type I trial. Our long-term goal is to develop a scalable and sustainable alternative yoga program to help Veterans with chronic pain who may not find other available pain management options to be appealing or effective. Eventually, we envision offering these classes both on and off VA campuses. Were this to come to fruition, the VA could use the program as a community outreach strategy to interest and engage Veterans in the community in the VA system of care. Ultimately, we hope that this program could improve access to quality care for Veterans.